Biophysical Determinants of the Nucleosome as an Activity Center for Chromatin Regulators

PROJECT SUMMARY/ABSTRACT
The fundamental unit of hierarchically organized eukaryotic chromatin is the nucleosome, which contains 147
base pairs of genomic DNA wrapped around an octamer of core histone proteins. Conventionally, nucleosomes
have been viewed as DNA packaging units that inhibit gene expression by obstructing the accessibility of DNA
to the transcriptional machinery. However, we and others have shown that nucleosomes also serve as potent
hotspots which recruit, modulate, and stimulate the activity of various essential chromatin regulators, indicating
a new role for nucleosomes in furnishing the genome with a multitude of physical features and interactions which
direct protein function. As such, I hypothesize that the physical characteristics and topology of nucleosomes
modulate the activity of chromatin regulators, constituting an underappreciated layer of physical parameters
encoded within chromatin architecture that govern genomic transactions in the nucleus. These parameters
include the shape and composition of the nucleosome core particle as well as the spacing and geometry of
contiguous nucleosomes in an array. To test this hypothesis, I propose to use single-molecule fluorescence
detection and force manipulation technologies established in my laboratory, which uniquely track real-time
transient and heterogeneous molecular interactions, to investigate the physical characteristics of nucleosome
topology that determine its capacity to tune the activity of several important classes of chromatin regulators at
multiple scales. We will first investigate how the topology of individual nucleosomes directs the DNA targeting
activity and cooperation of essential pioneer transcription factors (Aim 1). We will then probe how the geometry
of local nucleosomes in an array modulates the engagement, recruitment, and propagation of chromatin-
modifying enzymes on chromatin (Aim 2). Finally, we will investigate the biophysical basis of global nucleosome
localization and functionalization by energy-consuming molecular machines (Aim 3). Together, these studies will
zoom in on the topology of nucleosomes comprising a layer of biophysical parameters encoded within chromatin
architecture that regulate genomic transactions in the nucleus. They will contribute evidence towards a new
perspective that views nucleosomes as genomic regulators which harness their unique physical features to
actively modulate, recruit, and stimulate the activity of chromatin-associated factors, rather than passive DNA
packaging units. The proposed investigations will shed light on a nucleosome-focused angle for tackling several
long-standing questions about the interplay between chromatin and its regulators and promise to mechanistically
inform how disease-associated mutations perturb essential genomic activities, potentially revealing mutation-
selective protein-chromatin interfaces that may be therapeutically exploited to treat human disease.

Public health relevance
PROJECT NARRATIVE The packaging and organization of eukaryotic genomic DNA into nucleosome units provides a rich layer of physical characteristics and interactions that constitute an important feature governing the activity of many chromatin regulators in the nucleus. Leveraging single-molecule visualization and manipulation methods, this project aims to dissect how the physical topology of nucleosomes regulates the function of pioneer transcription factors, chromatin-modifying enzymes, and energy-consuming molecular machines in real time and at high resolution. Our studies will uncover how nucleosomes biophysically modulate the interaction between chromatin and its regulators and may reveal mutation-selective protein-chromatin interfaces linked to pathogenesis that are vulnerable to chemical intervention for treating disease.